Advancing Conformance with the Voluntary National Retail Food Regulatory Program Standards

Project REACH Abstract and Summary Washington is a home rule state with multiple local, state, and federal agencies responsible for retail food safety with no singular agency providing oversight. There are also twenty-nine sovereign tribal nations with potential food safety roles and minimal assistance from the state department of health. While non-centralized control allows local officials, tribes, and citizens the benefit of direct access and responsibility, the arrangement has led to concerns and challenges in retail food safety rule application, capacity, and succession. In Washington, only 18 out of 35 local health jurisdictions, one military base, and one state food safety program are enrolled in the US Food & Drug Administration Voluntary National Retail Food Regulatory Program Standards. Only one jurisdiction has met three standards; all other enrollees are meeting 0-1 standards. In order to increase consistency among the regulatory agencies, Project REACH (Reactivating Enrollees and Catalyzing Headway) will conduct a coordinated education and material development effort to increase the number of enrolled jurisdictions and improve the progress of stalled enrollees across eight standards. Project REACH will use current best practice and the 2017 FDA Food Code to prepare model policies and procedures, regulatory and industry training materials, and updated enforcement and field inspection guides. All educational materials will be based on two concepts common in food safety, active managerial control (AMC) and Hazard Analysis Critical Control Point (HACCP), to apply a known food safety practice to the less familiar concept of program improvement. This tandem approach will build on a current knowledge base and provide materials available for regulatory partners to use with industry. Additionally, the program intends to use outbreak investigation guidance from CDC’s National Environmental Assessment Reporting System (NEARS) and Council to Improve Foodborne Outbreak Response (CIFOR) to modify investigation report forms, materials, and protocols to train regulatory partners on illness reporting, response, and mitigation. In addition to meeting FDA Program Standards, all materials will also be consistent with Public Health Accreditation Board (PHAB) standards. The goals of Project REACH are to increase consistent and competent application of risk-based food safety procedures with a two-prong approach: increasing both enrollment and participation in Program Standards, preparing best practice materials that can be used with both regulatory and industry staff, meeting national standards from both FDA and PHAB, and using two common food-safety concepts (AMC and HACCP) to help improve both internal and external food safety effectiveness.

Public health relevance
Project REACH Narrative Project REACH will increase consistent and competent application of risk-based food safety procedures in a local control state with numerous regulatory authorities overseeing food safety. The project’s two-prong approach is designed to increase both enrollment and participation in FDA’s Retail Program Standards, prepare best practice materials that can be used with both regulatory and industry staff, meet national standards from both FDA and PHAB, and use two common food-safety concepts (AMC and HACCP) to improve both internal and external food safety effectiveness.